Community Liaison and Recruitment Core

ABSTRACT
The Resource Center for Alzheimer’s and Dementia Research in Asian and Pacific Americans (RCASIA)
has missions of 1) increasing scientists underrepresented in AD/ADRD-related Behavioral, Social, and
Economic Research biomedical research through innovative models of mentoring and community interaction;
2) advancing the rigor and impact of AD/ADRD pilot studies in older APAs through Common Data Elements
and data-sharing; 3) serving as a national resource for linguistically/culturally tested and validated tools to
assess cognition, function, and AD/ADRD care in APA populations. The Community Liaison and
Recruitment Core (CLRC) – led by Chau Trinh-Shevrin, PhD and Cui Yang, PhD – will facilitate the outward
engagement with community-based organizations, people with mild AD/ADRD, current/past care partners for
people with AD/ADRD, Minority Serving Institutions (MSIs) in the NYC/NJ area, and other academic institutions
hosting underrepresented Early Stage Investigators (ESIs). The CLRC will convene the Community Steering
Committee (CSC) consisting of Community Advisors (leaders and staff of community-based organizations
serving APA populations) and Lived Advisors (those with mild AD/ADRD, current/former care partners of
those with AD/ADRD) who will advise RCASIA Scientists on project-related linguistic/cultural relevance and
appropriateness of subject matter, tools, findings, and interpretations. The sharing of CSC membership with
other funded centers on APA health and intentional membership rotation will minimize the burden on local
volunteers, and enhance the sustainable long-term partnership among older APA populations, APA-serving
community-based organizations, and NYC/NJ-based institutions committed to APA brain health, health
disparities, and AD/ADRD-related behavioral, social, and economic research. The CLRC will further organize
open crowdsourcing contests to excite the community in research participation, and to pilot community-
derived ideas to diversify existing engagement approaches. Finally, CLRC will play a central role in identifying
underrepresented ESIs from the RCASIA parent/affiliated institutions, MSIs, and other academic organizations
in the greater NYC/NJ area. In addition to introducing RCASIA to and soliciting pilot applications from ESIs,
CLRC will encourage ESIs not experienced in submitting NIH-style pilot proposals to apply as RCASIA
Interns. Through an iterative yet balanced engagement of both underrepresented ESIs and specific APA
communities in the NYC/NJ area, CLRC will help RCASIA reach its goals of enhancing the AD/ADRD-related
behavioral, social, and economic research workforce while advancing linguistically/culturally appropriate
research and care in disaggregated APA subgroups.